Interdisciplinary Research Training on Health and Aging

Project Summary/Abstract
The proposed program, “Interdisciplinary Research Training in Public Health and Aging”
seeks a five-year continuation of the current award, which was funded originally in 2008,
and renewed in April 2014. The program will focus specifically on training opportunities in
the social and behavioral determinants of adverse health outcomes in older age, and their
mediation through or interaction with the biological mechanisms that are commonly thought
to be associated with aging-related changes in health. The rational for this focus lies in the
potential of this research to identify new opportunities for the prevention, management and
treatment of aging-related chronic health conditions and their functional consequences. The
program defines its disciplinary foundation in social epidemiology, while emphasizing
collaboration with scholarly activity from other disciplinary perspectives, including other
public health sciences, social sciences, biological sciences and medical sciences.
This application requests funds to support and train a total of 8 pre-doctoral trainees, with 2
new trainees being recruited each of the first 4 years of the program. The program will be
located in the Department of Epidemiology of the University of Michigan School of Public
Health. The Department of Epidemiology provides an exceptionally rich intellectual
environment for an inter-disciplinary training program in public health and aging, due to the
interconnections of its faculty with a large number of Research Institutes and Centers at the
University of Michigan. The training program includes 15 mentors with well-established
research and training records encompassing a variety of disciplinary backgrounds. The
training program consists of a structured program of teaching and mentoring with the
following inter-related components: 1) mentored research activity; 2) course work in the
epidemiology of aging and related subject matters, and participation in public health and
aging research seminars; and 3) participation in other training and enrichment opportunities
available at the University of Michigan.

Public health relevance
Project Narrative High quality training in public health and aging will prepare trainees to pursue productive careers in research and policy at the intersection of public health, social sciences, and other health sciences. The program is designed to help trainees develop new content and methods that will inform preventive, clinical and policy strategies aimed at improving the health and quality of life of future generations of older adults.